Project 3: GLP1R and GIPR Agonists in GEP NETs Project

Project 3 – Summary
Incretin mimetics that activate the glucagon-like peptide 1 (GLP-1) and glucose-dependent insulinotropic
polypeptide (GIP) receptors are increasingly prescribed in the U.S. for diabetes and obesity. These drugs
include the GLP-1 receptor (GLP-1R) agonist, semaglutide, and the dual GLP-1/GIP receptor (GLP-1R/GIPR)
agonist, tirzepatide. Gastroenteropancreatic (GEP) neuroendocrine tumors (NETs), one of the most prevalent
types of GI tumors, commonly express GLP-1R and/or GIPR. While GIPR expression appears largely
ubiquitous across GEPNETs, GLP-1R expression is more variable. Our pilot studies revealed that treatment of
receptor-positive GEPNET cell lines and patient-derived spheroids with these receptor activating agents
caused increased cell growth in vitro and xenograft tumor growth in vivo. With the rising use of these diabetes
and obesity drugs, high receptor levels on many GEPNETs, and delayed diagnosis of GEPNETs, it is possible
that these drugs will accelerate GEPNET growth leading to more advanced presentation at diagnosis. Thus, it
is critical to study how the different incretin mimetics affect GEPNET biology and progression. The central
hypothesis of this project is that GLP-1R and GIPR agonists selectively promote GEPNET growth
depending on expression levels of their targeted receptors.
• Aim 1. Define the specificity of GLP-1R vs GIPR expression in patient GEPNETs and
associations with clinicopathologic variables
• Aim 2. Establish the biological impact and receptor dependence of GLP-1R and GIPR agonists
in GEPNET models.
• Aim 3. Determine the impact of approved NET therapies, somatostatin analogues (SSAs) and
everolimus, on the effects of GLP-1R and GIPR agonists in GEPNETs
The exploding use of GLP-1R and/or GIPR incretin mimetics for obesity and diabetes may lead to unwanted
proliferation of cells expressing high levels of their receptors, which includes many NETs. Patients with occult
NETs who take these GLP-1R and/or GIPR agonists may therefore be at risk of developing more rapidly
progressive disease. Understanding the receptor dependence and mechanisms by which incretin mimetics
promote NET proliferation, as well as determining which patients are at highest risk, will inform how these
drugs may be used safely by NET patients. Specifically, our data suggest that GLP-1R specific agonists
(semaglutide) could be safe for patients whose NETs lack that receptor, whereas GIPR agonists (tirzepatide)
may have tumor promoting effects on most, if not all, GEPNETs due to widespread GIPR expression. This
project will define whether and how incretins can be given safely to NET patients. Our team is uniquely
equipped to address those questions, which have high clinical relevance and are in urgent need of answers.

Public health relevance
P3 – Project Narrative Incretin mimetics, which are increasingly prescribed in the U.S. for diabetes and obesity, are drugs that turn on GLP-1 and GIP receptors commonly expressed on neuroendocrine tumors (NETs). This project will be the first to 1) determine the predicted risks of incretin mimetic therapy in patients with gastroenteropancreatic (GEP) NETs that express high levels of these receptors, 2) define the biological impact, mechanisms of action, and receptor dependence of these drugs in human and mouse GEPNET models, and 3) test the possibility that current NET-approved therapies could be beneficial in blocking the tumor-promoting effects of these agents. Results should identify which NET patients may be at risk from incretin mimetic therapy, which incretin mimetic may be taken safely, and how unwanted incretin mimetic effects might be ameliorated.